Investigation of the innate and adaptive immune responses to TDP-43 aggregates in Amyotrophic Lateral Sclerosis

PROJECT SUMMARY
Sporadic amyotrophic lateral sclerosis (sALS) is the most common progressive motor-neuron disease, affecting
3 in 100,000 individuals 50 years or older worldwide. sALS is pathologically characterized by the presence of
hyper-phosphorylated, insoluble aggregates of the RNA/DNA binding protein Transactive Response DNA
Binding Protein (TDP-43). It is well established that aggregated TDP-43 causes dysfunction throughout the
central nervous system (CNS), ultimately resulting in neuronal cell death and symptom onset. However, the
exact molecular mechanism(s) by which aggregated TDP-43 imparts neurotoxicity has not yet been determined.
Recent evidence implicates innate immune cells, particularly infiltrating peripheral macrophages and microglia,
as a source of inflammation when stimulated by misfolded protein aggregates. This neuroinflammatory response
is therefore expected to compromise neuron integrity and contribute to neurodegeneration. Furthermore, and
adaptive immune cells, T- and B-lymphocytes, have been reported in post-mortem analyses of ALS brain and
spinal cord, however their mechanistic role in pathology remains unclear. This implicates both innate and
adaptive immune responses in sALS pathogenesis. Recent developments also suggest that microglia promote
secondary T-cell responses when stimulated by protein aggregates. This T-cell activation may then result in
direct neuronal death. Therefore, I hypothesize that aggregated TDP-43 causes a pro-inflammatory,
neurodegenerative cascade mediated by innate and adaptive immune responses that drives neurotoxicity
in sALS. In Aim 1, I will treat microglia with aggregated mammalian-derived TDP-43 and monitor modulation of
phagolysosomal integrity and inflammatory activation. Preliminary data using models of microglia treated with
TDP-43 aggregates demonstrate robust aggregate uptake and phagosome rupture. Additionally, mass
spectrometry analysis of TDP-43-treated macrophage cultures revealed an increase in pro-inflammatory and
immune activation factors, and markers of phagocytic dysfunction. In Aim 2, I will assess the ability of TDP-43-
treated microglia to promote motor-neuron death by way of T-cell activation. I will determine if TDP-43-
treated microglia engage with and promote CD4+ and CD8+ T-cell activation in culture. Finally, I will determine if
activated cytotoxic CD8+ T-cells prompt motor-neuron death in vitro using sALS patient-derived T-cells and
induced pluripotent stem cell (iPSC)-derived motor-neurons. In all, this work will use novel in vitro models to
elucidate the unknown mechanism by which TDP-43 aggregation leads to motor-neuron death and sALS onset.
This knowledge lends itself to biomarker and therapeutic development to improve diagnostic and treatment
strategies for sALS patients.

Public health relevance
PROJECT NARRATIVE Sporadic amyotrophic lateral sclerosis (sALS) is the most common incurable motor-neuron disease worldwide, and patients have an average five-year survival rate. The exact mechanism of sALS pathogenesis remains unknown, thereby hampering therapeutic development. Our work serves to elucidate the mechanism of sALS pathogenesis with a unique interdisciplinary approach that combines principles of molecular neuroscience and immunology to provide a platform for therapeutic development and improve the clinical status of sALS patients.